Building testing capacity for past and current SARS-CoV-2 infection in animals with potential exposure to humans with COVID-19

Project Abstract The goal of this proposal is to build testing capacity at the Wisconsin Veterinary Diagnostic Laboratory (WVDL) to perform serology detection and whole genome sequencing of SARS- CoV-2 from animal samples. We are requesting funding for the purchase of reagents and equipment to validate the SARS-CoV-2 Surrogate Virus Neutralization Test kit (GenScript) as a multi-species diagnostic serology assay, with specific focus on the detection of antibodies against SARS-CoV-2 virus in companion animals. As part of a proposed Genomic Consortium, we are requesting funds to purchase a QIAxcel Adnavced System (Qiagen) and a MinION (Oxford Nanopore) Enhanced Pack to validate library preparation and sequencing kits for iSeq (Illumina) and MinION for targeted SARS-CoV-2 sequencing. We will participate in the development and validation of bioinformatics pipelines that will be made accessible to veterinary diagnostic personnel to quickly and efficiently determine genomic lineages, and develop a staff training and development program to maintain proficiency in sequencing and to analyze the SARS-COV-2 genome. Together, we aim to have a validated multi-species serological diagnostic assay and trained staff with streamline workflow for whole genome sequence of the SARS-CoV-2 virus detected in animal specimens, to increase our capacity and capability to support diagnostic activities for the ongoing global SARS-CoV-2 pandemic. In turn, the acquired equipment and training will help building WVDL’s readiness to response to potentially other important future veterinary disease outbreaks that are important to human food safety and animal welfare.

Public health relevance
Project Narrative This proposal is focused on building capacity at the Wisconsin Veterinary Diagnostic Laboratory (WVDL) with development and validation of a SARS-CoV-2 serological assay and improved WGS methodology and training as we continue to collaborate with the Genomic Consortium led by the University of Georgia. Funding is requested for the purchase of reagents and equipment to validate the SARS-CoV-2 Surrogate Virus Neutralization Test kit (GenScript) as a multi-species diagnostic serology assay, and to validate a targeted SARS-CoV-2 sequencing workflow using the MinION (Oxford Nanopore) and the iSeq (Illumina) platforms. This project will further our capacity and capability to support diagnostic activities for the ongoing global SARS-CoV-2 pandemic and potentially other important future veterinary disease outbreaks that are important to human food safety and animal welfare.